Developing a toolbox to study proteome plasticity in brain endothelial cells

Neurons lack substantial energy stores and thus their function is critically dependent on the timely delivery of
energy substrates in the blood. Precise control of brain blood flow is therefore essential for brain health. However,
the exact mechanisms through which cerebral hemodynamics are regulated remain unclear. Furthering our
understanding of this control is critical, as it is increasingly appreciated that disruption of brain blood flow is one
of the earliest pathological events in Alzheimer’s disease and related disorders and may be a key contributory
factor to disease progression and neurodegeneration. Thus, advancing our understanding of the mechanisms of
brain blood flow control may reveal novel and much needed targets for therapeutic interventions.
Neuronal energy requirements vary greatly across the wide range of tasks that they perform, and this raises the
possibility that energy delivery mechanisms have to be flexibly adapted to meet these needs. Our recent work
has revealed a novel and surprising form of plasticity in brain blood flow control mechanisms, which we refer to
as “Vascular Signaling Plasticity” (VSP). Here, the strength of mechanisms for blood flow control in brain
capillaries are reprogrammed according to changes in local neuronal energy needs. Indeed, our data show that
when neuronal energy demands are increased in the barrel cortex, the strength of a key Kir2.1 channel-
dependent capillary-to-arteriole electrical signaling pathway that controls blood flow is augmented through a
mechanism involving epigenetic reprogramming of capillary endothelial cells which ultimately modifies
membrane density of Kir2.1. Surprisingly, our further investigations into the molecular mechanism of VSP
strongly suggest that this process involves ribogenesis which in turn reprograms the translatome of the cell.
Using these exciting findings as a springboard, we propose to apply two technologies to capillary endothelial
cells—RiboTag and Puro-PLA—to enable us to elucidate the mechanism of VSP in granular detail. In Aim 1, we
will directly quantify ribogenesis in capillary endothelial cells undergoing VSP and we will use RiboTag
technology to isolate ribosomes from brain capillaries and perform an unbiased RNA-seq screen to identify
changes to the translatome of these cells during VSP. In Aim 2 we will apply puro-PLA to capillaries undergoing
VSP, which will enable both the broad visualization of proteins undergoing translation, and the specific tracking
of proteins of interest involved in blood flow control.
Completion of this work will thus reveal novel aspects of the VSP mechanism and may identify novel therapeutic
targets in brain capillaries and could lay the groundwork for much needed treatments aimed at protecting or
rescuing blood flow in brain disorders with a vascular component.

Public health relevance
Our recent work has revealed a surprising and novel form of plasticity in the mechanisms that the smallest blood vessels—capillaries—use to control brain blood flow that we suspect is very important for ensuring that energy delivery is exactly matched to the needs of brain cells to protect their health and function. Here, we will use two techniques (“RiboTag” and “Puro-PLA”) that have not been applied to brain blood vessels before to study the changes to protein production that occur in blood vessels that are undergoing these plastic changes. Through this work we will expect to uncover unique insights that may help to identify novel drug targets in brain blood vessels for therapies that aim to protect or restore blood flow in brain disorders with a blood flow component.